Characterization of Chronic Contusive Spinal Cord Injury and Promotion of Corticospinal Tract Regeneration

Characterization of Chronic Contusive Spinal Cord Injury and Promotion of
Corticospinal Tract Regeneration
Summary
Chronic spinal cord injury (SCI) is a post-injury stage when the injury is stable with little additional
change. Although the vast majority of SCI are chronic, there are few studies to characterize the chronic
injury at histological, cellular, and molecular level in clinical relevant animal models. There are even
fewer studies for development of therapeutic treatment of chronic SCI, especially for promotion of
supraspinal motor axonal regeneration, including the corticospinal tract (CST) system that is the most
important voluntary motor control system in humans. Therefore, we propose to use a chronic clinical
relevant moderate bilateral lower cervical contusion model for characterization it at cellular and molecular
levels and development of new therapies for improvement of skilled hand function.
There are three Specific Aims in this proposal. Aim 1 is to identify cellular mechanisms associated
with chronic contusive SCI, to guide discovery of new molecular mechanisms to promote
regeneration. We will develop a moderate chronic bilateral lower (C6) cervical contusion model since
the majority of SCI patients (65%) are quadriplegic, with loss of hand function that is critical for
independence and quality of life. The injured rats survive for up to 12 months to a chronic stage of SCI
for characterization of glial scar, extra cellular molecules (ECM) and axonal state. Aim 2 is to identify
transcriptional mechanisms associated with chronic contusive SCI, to guide discovery of new
molecular mechanisms to promote regeneration. We will use a newly developed technique
developed in our lab, Cre-dependent Ribotag vectors, to isolate mRNA specific from chronically injured
CST neurons for characterization of their transcriptome using RNAseq. We then compare this
transcriptome to intact and sub-acutely injured CST neurons (we already have these datasets) and
chronically injured CST neurons that regenerate into neural progenitor cell (NPC) graft to identify key
molecular pathways related to cellular/axonal growth that are disrupted, We can therapeutically target
these molecular pathways in Aim 3 and future studies. Aim 3 is to test candidate mechanisms to
promote recovery of chronically injured CST neurons and promote axonal regeneration after
chronic SCI. We will first perform in vitro screen for the potential candidate targets identified in Aim2 to
promote neurite growth of postnatal cortical neurons and adult dorsal root ganglion (DRG) neurons. We
then test these candidate genes to promote regeneration of chronically injured CST in combination with
NPC transplants that serve as a permissive cellular substrate. Findings of this work will substantially
extend our knowledge of chronic SCI and develop potential treatment for chronic SCI.

Public health relevance
Spinal Cord Injury (SCI) is damage to the spinal cord that results in permanent loss of function such as mobility or feeling below injury. There are approximately 270,000 Americans living with SCI, and approximately 20,000 of those injured are Veterans (data from Paralyzed Veterans of America). The number of such injuries is increasing as a result of the Afghanistan war. Thus, care and treatment of spinal cord injured veterans is important to the VA patient care mission. Corticospinal tract (CST) is a very important descending motor system that controls voluntary movement in humans, and appears to be the most refractory motor system from which to elicit regeneration. The proposed study is to characterize a clinical relevant chronic moderate bilateral lower cervical contusion model at cellular and molecular levels and to develop new therapies. The success of this project will benefit those veterans and civilians who suffer SCI.